Translational Research in Alzheimer's Disease and related Dementias (TRADD)

Project Summary/Abstract
The University of Arizona (UArizona) Training Program to Advance Translational Research on Alzheimer's
Disease and AD Related Dementias (AZ-TRADD) is designed to address knowledge and experience gaps in AD
therapeutic discovery and preclinical translational development. To meet this challenge, the UArizona
Translational Research in AD and related Dementias (AZ-TRADD) training program is designed as a problem
based translational learning experience for predoctoral Ph.D and M.D./Ph.D fellows. In alignment with the 2021
NIH Alzheimer’s Research Summit: Path to Precision Medicine for Treatment and Prevention and the 2011
National Alzheimer’s Project Act (NAPA), the goal of the AZ-TRADD training program is to fill critical gaps that
exist for AD translational research in academic graduate programs. To achieve this goal, the AZ-TRADD program
will: 1) recruit trainees across multiple scientific disciplines; 2) employ problem-based learning approaches to
solve challenges in AD therapeutic development with emerging tools and techniques; and 3) equip AZ-TRADD
trainees with career development and leadership skills necessary to conduct team science and manage
multidisciplinary teams. Through this approach, we ensure that AZ-TRADD trainees develop deep translational
research expertise necessary for AD therapeutic development, while: 1) cultivating the ability to creatively and
collaboratively solve problems working with experts across the translational landscape as part of large-scale
team science; 2) gaining an applied understanding of how data science, particularly using data generated by
AMP-AD, M2OVE-AD and ADNI, can accelerate translational research and provide avenues to novel therapeutic
insights; 3) connecting geno- and phenotypic variations and multifaceted etiology of AD to therapeutic targets;
and 4) gaining essential professional and business skills to navigate a diverse funding landscape and translate
discoveries into the clinical setting. AZ-TRADD fellows will receive career mentoring and leadership development
skills to manage multi-disciplinary teams in the 21st century that is Patient Inspired and Data Driven. The AZ-
TRADD training program will develop a diverse, cross-disciplinary, and translationally oriented workforce to meet
the critical challenge of creating a workforce capable of advancing therapeutics to prevent, delay, and treat AD
and AD related dementias.

Public health relevance
The University of Arizona Training Program to Advance Translational Research on Alzheimer's Disease and AD Related Dementias is designed to create a workforce capable of developing therapeutics to address the national and global crisis of Alzheimer’s disease.